A Single-Cell Transcriptome Atlas for Zebrafish Development

Safe, effective therapies generally target specific disease-related molecules that appear only in disease-related
cell types. The problem: Gaps in our knowledge include a comprehensive definition of cell types in any
vertebrate species over developmental time and knowledge of which genes each cell type expresses at what
levels. Genes currently known only by sequence might provide unique targets for cell therapies if we knew
which cell types express them. A way forward: It has recently become possible to identify the transcriptional
profile of individual, single cells with unprecedented molecular precision using single-cell RNA sequencing
(scRNA-seq) coupled with powerful highly dimensional-reducing software that groups cells into
bioinformatically identified clusters containing cell types with closely related gene expression profiles. The
goals of this project are first, the comprehensive identification of transcriptionally unique cell types over
developmental time in zebrafish, a major medical model, and second, the release of these data as a resource
to the research community in a convenient searchable format through the Zebrafish Information Network
(ZFIN). Approach: Aim 1 is to define single cell transcriptome phenotypes for various stages of wild-type
zebrafish embryos, larvae, and juveniles and to locate these annotated cell types by in situ hybridization
experiments displaying the expression of cell type-specific marker genes on whole mounts and histological
sections. Aim 2 is to define the single cell transcriptome phenotype for all major organs in wild-type zebrafish
adult males and females and to identify prominent cell types in vivo by in situ hybridization for cell type-specific
marker genes on histological sections. Aim 3 is to develop an automated bioinformatic pipeline to identify cell
types in scRNA-seq clusters by comparing gene expression profiles to existing resources, including ZFIN,
other model organism databases (AGR, Alliance of Genome Resources), and human gene expression data.
Aim 4 is to develop an interface in ZFIN to enable the research community to easily query zebrafish scRNA-
seq data. Innovation: No animal species currently has a comprehensive compendium of cell types organized
by gene expression patterns on a genome-wide scale during development. Significance: This R24 application
will develop resources and related materials that will 1) enhance, further characterize, and improve a critical
animal model for the investigation of human disease mechanisms; 2) facilitate access to data generated from
the use of animal models of human disease; and 3) address the research interests of many categorical NIH
Institutes and Centers that focus on various organ systems and disease types. This resource will identify
previously unknown cell types, thus facilitating the precision targeting of cell types for potential therapies; will
associate previously unknown genes with specific cell types, thus increasing potential molecular targets for
drug therapies; and will suggest hypotheses for gene expression networks, thus improving our knowledge of
cellular mechanisms in health and deepening our understanding of gene interaction webs in disease etiology.

Public health relevance
NARRATIVE Effective therapies with few side effects target specific molecules within unique cell types, but we lack a comprehensive understanding of human cell types and the genes they express. This project will exhaustively define cell types by their genome-wide gene expression patterns for embryonic, juvenile, and adult zebrafish, a medical model organism with a backbone that is readily manipulated for functional studies and possesses organs, tissues, cells, and genes that function like those in humans (for example, amacrine cells in eyes, T- cells in immunity, melanocytes in the skin, pancreatic islet cells, hair cells in the ear, nephrons in kidneys, growth hormone-secreting cells in the pituitary, melatonin-producing cells in the pineal, and estrogen-producing cells of the ovarian follicle, to name a few). The project’s outcome will be the comprehensive characterization of cell types by the genes they express provided in a publicly available extensive model organism database (‘ZFIN’), along with the discovery of novel cell types, expression data for previously unstudied genes, and hence knowledge that will facilitate the development of more precise therapies and greater understanding of cell function in human health and disease.